Tox-AD: a new multi-institute tri-consortium data resource in the AD Knowledge Portal

Abstract
This supplement will expand the AD Knowledge Portal (adknowledgeportal.org) by incorporating
data being generated by a high-value set of projects that are using complementary approaches
to characterize how multiple environmental toxicants, such as heavy metals, air pollution,
infection, pesticides, and other chemical exposures, affect the development of AD/ADRD. Three
projects, encompassing 11 U01 grants, will be generating new multi-omic data from model
systems (cell line, organoid, and mouse) and from tissues collected from established
longitudinal human cohorts. Data types that will be generated and shared include epigenomics,
transcriptomics, proteomics, metabolomics, genetics, cytokine data, exposure biomarkers, and
others. These data will be of high interest to the research community, as they will illuminate how
common exposures may influence pathways to disease at the molecular level. We will support
dissemination of these valuable research assets through the AD Knowledge Portal, which
serves as an NIH designated repository to support the NIA’s strategic goal to propagate data
sharing under FAIR principles and to promote open science.

Public health relevance
Narrative Alzheimer's disease is a complex disorder that affects an expanding number of individuals globally, but there are few treatment options, and none that can prevent symptoms from arising. The National Institute on Aging has funded a new tri-consortium (Tox-AD) to investigate the effects of environmental exposures on AD/ADRD risk using model systems, human cohort data, and systems biology approaches. The highly valuable data and analytical results generated by Tox-AD projects will be made publicly available through the AD Knowledge Portal (adknowledgeportal.org) in order to accelerate the pace of AD research.